Discovery and Characterization of Novel Halogenases from the Human Microbiome and from Archaea

PROJECT SUMMARY/ABSTRACT
Flavin-dependent halogenases (FDHs) are biosynthetic enzymes from bacteria and fungi that
catalyze regioselective C-X bond formation (X=Cl, Br) with various aromatic substrates. Their
regioselectivity and environmentally friendly reaction conditions make FDHs attractive candidates for green
synthesis of aryl halides to be used in transition metal catalyzed cross-coupling reactions. The proposed
project will expand our understanding of regioselective aryl halide formation by FDHs through the
identification and structural and enzymatic characterization of novel members of this family of enzymes,
expanding the FDH toolkit by adding new members with different substrate and halide selectivities to the
currently characterized enzymes. In Specific Aim 1 of this project, we will continue our characterization
the extended substrate scope of AbeH and BorH, two FDHs from soil bacteria metagenomes that we have
shown can chlorinate and brominate tryptophan to produce two different regioisomers. In the last project
period, we have identified 21 and 25 additional substrates that can be halogenated by BorH and AbeH
have begun the process of identifying and characterizing the specific halogenated products, which include
pharmaceutically relevant compounds such as 4-chlorokynurenine and 1-(4-chlorophenyl)-piperazine.
Aim 1 will also investigate the full substrate scope of Hal4, a novel FDH produced by the human
microbiome that we recently identified. We also intend to continue our crystallographic analysis of FDH-
substrate interactions by solving crystal structures of BorH and Hal4 with various substrates bound to
understand how the enzyme recognizes, binds, and orients these substrates to produce specific
regioisomers. Specific Aim 2 continues the work that we began during the last project period with the
identification of Hal4 and involves continued the data mining of human microbiome metagenomes for
genes that encode novel FDHs. Our discovery of Hal4 validated our hypothesis that FDHs are produced
by the bacteria of the human microbiome, where they may be involved in generate secondary metabolites
that play a role in chemical communication between bacteria and human cells. We have identified an
additional 25 putative FDH genes from the human microbiome as well as two from archaea and two from
other bacterial metagenomes, and these will be expressed and purified so their structures and activities
can be characterized. Specific Aim 3 is a new aim for this renewal and involves the investigation of
differences in absorbance and fluorescence properties between various FDH substrates and their
halogenated products for the purposes of identifying wavelengths and methods that can be applied to
continuous real-time assays for FDH activity, for use in high-throughput screening of novel FDHs as well
as for kinetic analysis.

Public health relevance
PROJECT NARRATIVE Flavin-dependent halogenases catalyze regioselective chlorination, bromination, or iodination of aromatic compounds and we are interested in identifying novel members of this family in order to improve their potential to be used as biocatalysts for an environmentally friendly green chemistry approach to synthesis of aryl halides, key building blocks for pharmaceuticals that treat a wide variety of conditions, as well as agrochemicals and other commercially important molecules. This project will identify and characterize new flavin-dependent halogenase enzymes produced by the bacteria of the human microbiome, the unique community of microorganisms that inhabit our gut, skin, and other tissues and contribute to human metabolism, immunity, and brain function. It will also develop new analytical methods to study the rates of the reactions carried out by these enzymes and how those rates are different for different substrates and under different conditions.